The Effects Of Structure-based Deglycosylation Of Hiv-1

In this study, guided by the X-ray crystal structure of gp120, we deleted four N-linked glycosylation sites that flank the receptor-binding regions. We examined the effects of selected changes on the sensitivity of two prototypic HIV-1 primary isolates to neutralization by antibodies and binding to the envelope glycoproteins by neutralizing antibodies.